Hypoxia-Inducible Factors and Neutrophil Heterogeneity in Myeloproliferative Neoplasm-Associated Venous Thrombosis

PROJECT SUMMARY/ABSTRACT
This K08 Career Development Award details a 5-year training program to advance my career goal of becoming
an R01-funded physician-scientist focused on elucidating thrombotic mechanisms in myeloproliferative
neoplasms (MPN) in order to find new treatment targets and improve care of MPN patients. During the award
period, I will continue developing expertise in mechanistic understanding of and models of thrombosis, acquire
new scientific skills, advance translational capabilities, and generate publications and data that will serve as the
foundation for a successful R01 application. Under the guidance of my primary mentor, Dr. Rafal Pawlinski, and
co-mentors, Drs. Jonathan Serody and Alison Moliterno, these training objectives will be met by a combination
of didactic course work, participation in seminar series, research experience, and mentoring by my advisory
committee. Dr. Nigel Key and Dr. Josef Prchal will serve as advisors on the proposal.
The scientific proposal is aimed at identifying thrombotic mechanisms in JAK2V617F-positive MPN. Thrombosis
remains the leading cause of mortality in the major MPN subtypes polycythemia vera and essential
thrombocythemia. Circulating blood cells are both increased in quantity and qualitatively abnormal in MPN.
Current treatment paradigms aim to normalize the number of circulating blood cells to improve blood rheology.
However, despite current therapies 25% of MPN patients will experience a thrombotic event after diagnosis.
Understanding the basis of thrombosis and developing primary and secondary prevention strategies are key
unmet needs in this field. Dr. Prchal and I recently reported that upregulation of hypoxia-inducible factor (HIF)-
mediated gene expression in neutrophils of MPN patients associated with thrombosis history. Importantly, we
also found increased neutrophil gene expression of tissue factor (TF), the primary initiator of the extrinsic
pathway of coagulation. We extended this finding, demonstrating that MPN neutrophils possess TF
procoagulant activity. Plasminogen activator inhibitor-1 (PAI-1) is the primary physiologic inhibitor of fibrinolysis;
its gene expression was also increased in MPN patients. I therefore hypothesize that JAK2V617F-driven increases
of HIF activity leads to upregulation of TF and PAI-1, thereby increasing the risk of MPN thrombosis. In Aim 1,
I will use a mouse model of venous thrombosis (VT) to evaluate (1) the functional consequence of increasing
JAK2V617F transgene copies to VT, (2) the effect of HIF-1α or HIF-2α inhibition to VT, (3) the contribution of
JAK2V617F mutation in hematopoietic versus endothelial cells to VT, and (4) the effect of neutrophil TF to VT. In
Aim 2, I will evaluate the effect of 0, 1, or 2 JAK2V617F-mutated alleles on heterogeneity of neutrophil gene
expression in MPN patients using single cell RNA sequencing with overlayed single cell genotyping. The 2 Aims
are complementary but independent and will identify new targets for the prevention of MPN thrombosis and set
the stage for additional investigations.

Public health relevance
NARRATIVE Thrombosis is the leading cause of mortality in patients with myeloproliferative neoplasms (MPN), yet little is understood about the mechanism driving this increased risk. Hypoxia-inducible factor (HIF)-mediated upregulation of genes including tissue factor in neutrophils from MPN patients associates with thrombosis history. This proposal aims to evaluate the role of HIF in MPN-associated thrombosis.